Sex Specific Effects of Adolescent Alcohol Exposure on BNST Plasticity

Summary/Abstract: Linh Ha is a phenomenal first-year graduate student that will be joining my
lab in May 2023. She is a Vietnamese American that grew up in New Orleans, LA. Linh qualifies
for this diversity supplement under the “Individuals from disadvantaged backgrounds” and meets
four of the seven criteria including: 1) have/had no parents or legal guardians who completed a
bachelor’s degree, 2) were or currently are eligible for Federal Pell grants, 3) were eligible for the
Federal Free and Reduced Lunch Program for two or more years, and 4) grew up in a “Centers
for Medicare and Medicaid Services-designated Low-Income and Health Professional Shortage
Areas”. The goal of the funded parent grant, R01AA028011-01A1, is to investigate the long-term
sex-dependent changes in BNST plasticity and negative affect behavior from adolescence alcohol
exposure and adult stress. Specifically, it evaluates the sex-dependent impacts of adolescent
alcohol and stress on 1) the enhancement of glutamatergic inputs [via CRF-CRFR1 signaling], 2)
BNST plasticity in specific projection regions, and 3) negative affect behavior. This diversity
supplement describes a research plan that will extend this work to test the overarching hypothesis
that BNST-kappa opioid receptors (KORs) regulate the sex differences in BNST plasticity and
negative affect from adolescent alcohol exposure and stress. BNST-KORs are known to be
important in alcohol withdrawal, stress, and negative affect but the interaction of these factors has
not been explored in the context of adolescent alcohol exposure or across sex. The technical
skills utilized in this research plan (especially electrophysiology) will set Linh apart when entering
the job market for a postdoc position. LSUHSC is also great environment for graduate training
and will allow Linh to gain expertise in alcohol research, professional development skills,
grantsmanship training, and opportunities to share her work.

Public health relevance
Project Narrative Understanding of the development of anxiety/depression during alcohol withdrawal is critical to the prevention of relapse during alcohol abstinence and overall treatment of alcoholism. This project investigates the effects of adolescent alcohol use on a primary neurotransmitter system (glutamate) in key brain areas (the extended amygdala) known to be important for the development of anxiety/depression. These studies also explore differences in the development of these behaviors between sexes.